PLATELET MITOCHONDRIAL METABOLISM IN DEGENERATIVE NEUROLOGIC DISEASE

Platelets will be collected by platelet pheresis from normal volunteers and patients with neurologic disease. Platelet mitochondria will be isolated and mitochondrial chemistry will be investigated.